Technology Train Dis: The Center for Advancing Point of Care Technologies in Heart, Lung, Blood and Sleep Diseases

PROJECT SUMMARY/ABSTRACT – TECHNOLOGY TRAINING AND DISSEMINATION
CORE
A major function of the Center for the Advancement of Point-of-Care Technologies (CAPCaT) in
heart, lung, blood, and sleep (HLBS) diseases is to train innovators developing novel point-of-
care technologies (POCT); and disseminate both those technologies and insights about the
product development process to a wide group of stakeholders. Heart, lung, blood, and sleep
(HLBS) disorders are the major cause of morbidity and mortality in the US, despite decades of
research and substantial improvements in treatments, prevention and outcomes. Health care is
undergoing a transformation in care delivery from medical centers and office-based settings to
remote-monitoring and home-based care. The development of POCT will greatly facilitate and
accelerate this transformation by: 1) providing methods to monitor health/medical status in
people as they go about their daily lives outside the clinic; 2) delivering actionable reports to the
point of care; and 3) providing rapid feedback to caregivers and patients to improve patient self-
care, symptom detection, diagnosis, and treatment delivery. POCT product development is
challenging because of the need to integrate disparate disciplines such as human biology,
engineering, software, and device development. New models are emerging in both academia
and industry to implement cross-functional development teams and to speed the translational
process. A key element of success is the development of novel training programs to expose
POCT developers and users to the clinical and process issues related to device development,
validation and commercialization. CAPCaT will develop and lead innovative teaching programs
and leverage complementary educational opportunities to provide a comprehensive training and
dissemination plan for the POCT development community. Highlights of this program will
include a short-course modeled on the NSF/NIH I-Corps program, a dynamic educational series
on the clinical and process elements of POCT development, and an annual stakeholder
showcase day. The knowledge generated through these programs will, in turn, be used to
inform other core activities of CAPCaT.

Public health relevance
The Center for Advancing Point of Care Technologies (CAPCaT) in Heart, Lung, Blood, and Sleep Diseases identify, evaluate and support point-of-care technologies in heart, lung, blood, and sleep disorders for diagnosis, monitoring and interventional delivery. Point of care technologies have the potential to improve both the quality and efficiency of health care in these diseases, as well as increase the role of the patient as a decision-maker in care.